BICARBONATE KINETICS IN HUMAN PREGNANCY

The purpose of this study is to (1) quantify the recovery of labeled CO2 in breath during a primed constant infusion of sodium 13C bicarbonate in human pregnancy, during fasting and in response to feeding and (2) to examine the effect of advancing gestation on these parameters.